Improving statistical methods for small area estimates of public health indicators and demographic characteristics

SPATIAL UNCERTAINTY IN SMALL AREA ANAYLSIS FROM SURVEY AND ADMINISTRATIVE DATA ABSTRACT Small area data are ubiquitous in public health including incident or prevalent disease counts, population sizes, socioeconomic covariates, and environmental exposures. Geographic information systems (GISs) link and merge such data but do not account for multiple sources of uncertainty. Small area estimation and disease mapping techniques provide tools for maintaining geographic precision of smaller areas and statistical precision of larger sample sizes via “borrowing information” from neighboring areas. To date, these methods do not readily incorporate design-based uncertainty from the components. Our proposed research project involves the development of statistical methodology and associated software tools as part of an evolving reproducible workflow to incorporate local population and covariate uncertainty into spatial models of disease risk.

Public health relevance
SPATIAL UNCERTAINTY IN SMALL AREA ANAYLSIS FROM SURVEY AND ADMINISTRATIVE DATA NARRATIVE Population counts and socioeconomic variables from small geographic areas provide critical information for geographic studies in public health but often arise from multiple sample-based estimates and with heterogeneous sources and levels of error. Our research program develops novel statistical approaches to measure and adjust for multiple sources of local variability providing increased accuracy and reliability in small area estimates of health risks.